Mitochondrial Energy Sensing and Neuronal Function

Neurons integrate multiple inputs and coordinate a series of molecular events to drive cellular function.
During neurotransmission, electrical depolarization at the pre-synaptic axon is transduced to chemical signals
that affect post-synaptic dendrites. Neurons depend on mitochondrial function for survival. At the center of
mitochondrial function is the protonmotive force (PMF), an electrochemical proton gradient that coordinates
metabolic signaling and energetic responses. The PMF acts like a ‘bioenergetic battery’ and the stored electrical
energy is used to uptake metabolites, make ATP, alter reactive oxygen species production, and buffer cellular
calcium signaling. The PMF is dynamic and fluctuates in biology to drive cellular differentiation and autophagy,
while the loss of PMF is associated with neurodegeneration and cell death. Maintaining PMF is required for
neuronal function, and the neuronal architecture offer unique cellular environments. Distinct neuronal regions
have unique biological constraints and mitochondrial energetic demands. Likewise, mitochondrial morphology
and function are also specialized in a compartment-dependent manner. How neurons fuel cellular processes
and how individual mitochondrial populations modulate energetics in each neuronal compartment remains poorly
understood in part due to the lack of tools offering cell-specific and spatiotemporal control of the PMF.
This R01 renewal addresses this gap in the field by leveraging discoveries from the previous funding
period, where we developed a novel optogenetic approach to independently control, both spatially and
temporally, the PMF in vivo. The neuronal cell membrane potential integrates and regulates numerous facets of
neuronal signaling and health. Much like the neuronal membrane potential, we propose that the mitochondrial
PMF acts as a central integrator to transduce signaling and power a wide array of cellular pathways and
functions. We hypothesize that neuronal responses to mitochondrial energetics are highly dependent on the
timing, duration, and location of the mitochondrial perturbation. Controlling the PMF has been a long-standing
challenge in mitochondrial biology. Here, we propose to use light to increase or decrease the PMF in distinct
neuronal compartments and dissect the effects on neuronal function. Accumulating evidence demonstrates that
altering energy status has wide ranging effects on neuronal function. We will determine the spatiotemporal tenets
defining mitochondrial PMF signaling across neuronal compartments and how these signals affect neuronal
activity and in vivo behavior. Addressing the neuropathologic heterogeneity of mitochondrial function in neurons
will advance the field and define novel, targeted approaches to guide therapeutic strategies targeting
neurodegeneration.

Public health relevance
Mitochondria are essential for neuronal health, but dissecting the contribution of individual bioenergetic outputs and associating dysfunction with disease is hampered by a lack to tools to precisely control mitochondrial functional parameters. Moreover, the importance of these parameters can vary depending on their physical and metabolic context, or where within the complex architecture of a neuron mitochondria reside. Our research program develops and utilizes unique genetic and optogenetic tools that enable us to address these questions with unmatched precision and accuracy, leading to a more nuanced understanding of the critical role mitochondrial dysfunction plays in neuronal pathophysiology.